Early detection and inference for emerging infectious agents in data-sparse settings

PROJECT SUMMARY/ABSTRACT
In the last few decades, novel pathogens have emerged at an unprecedented rate, causing significant health
and economic burdens in our society. However, our ability to detect and quantify key epidemiological features
of these pathogens has been limited during the early phase of outbreaks – a critical but short time window to
understand new diseases. This gap arises primarily due to a lack of observational data and incomplete
detection of transmission events, constrained by the resources invested in traditional surveillance systems. Our
research group has been at the forefront of developing mathematical models and computational tools to
advance the methodology for surveillance, inference, and forecasting of emerging infectious agents, including
SARS-CoV-2, pandemic influenza, and antimicrobial-resistant organisms (AMROs). Our goals for the next five
years are to develop novel computational tools to detect early signals of cryptic transmission and infer critical
epidemiological features in data-sparse settings. Leveraging theories in complex systems and advanced
techniques in machine learning and deep learning (ML/DL), we propose to synergistically use traditional (e.g.,
syndromic surveillance, PCR tests, sequencing, human mobility, and contact tracing) and non-traditional (e.g.,
wastewater, social media, and search queries) data sources to conduct a series of studies centering on three
key questions. 1). How can we detect early transmission of emerging infectious diseases? We will take a
biomimicry approach, inspired by the mechanism of the human physical sensation system to detect external
stimuli (e.g., light, sound, and pressure) spanning several orders of magnitude in intensity. We will develop and
optimize excitable sensor networks that collectively assimilate a multitude of data sources in different locations
to assess the transmission potential for novel pathogens. 2). How can we infer key epidemiological features of
novel pathogens using limited data? We will combine process-based models (e.g., metapopulation and agent-
based models) and ML/DL techniques (e.g., Graphical Neural Networks and Transformers) to identify
signatures of disease characteristics, such as asymptomatic shedding and superspreading, using early-stage
data. 3). How can we validate model-derived hypotheses to reduce uncertainty? Determining characteristics of
novel pathogens is a high-stakes task. We will develop strategies (e.g., sampling in specific locations at certain
times) to cost-effectively validate hypotheses on spatial spread of new viruses and gather new evidence in real
time to reduce uncertainty. For all three projects, the developed methods will be applied to a range of infectious
agents with disparate epidemiology, including SARS-CoV-2, influenza, AMROs, and zoonotic viruses. We will
apply new methods to retrospectively acquired data and quantify their advantage over classical approaches
(e.g., how much data is needed with classical versus new methods). Our vision of the research program is that
the synergistic use of computational tools and diverse data sources can enhance our ability to perform timely
and impactful research to understand novel pathogens using sparse and imperfect data.

Public health relevance
PROJECT NARRATIVE Our ability to detect emerging infectious diseases and quantify their key epidemiological features has been limited by sparse observational data during the early phase of outbreaks. This project will develop novel computational tools to detect early signals of cryptic transmission and infer critical epidemiological features in data-sparse settings, leveraging a multitude of data sources and advanced techniques in complex systems, machine learning, and deep learning. The proposed studies will be validated using distinct disease systems including respiratory diseases, antimicrobial resistant pathogens, and zoonotic spillovers and produce generalizable methods to understand novel pathogens using sparse and imperfect data.